DANDI: Distributed Archives for Neurophysiology Data Integration

Neuroscientific data contain information from an incredible diversity of species and modalities that are
generated by a plethora of devices, and encapsulate the results of scientific thinking and decision making. The
BRAIN Initiative has spearheaded a comprehensive informatics initiative to gather much of this neuroscientific
data into standardized representations and to disseminate it through accessible platforms. DANDI -
Distributed Archives for Neurophysiology Data Integration, is one such current effort to facilitate the
aggregation and dissemination of neurophysiology research data using best practices and standards, and has
grown to accommodate about 400TB of data across 100+ published datasets in slightly over 2 years. The
archive supports a broad range of users with different levels of expertise by providing a spectrum from
Web-based to programmatic mechanisms to access and upload data and helps improve the expertise through
training of the scientific user base through tutorials and workshops. We expect future datasets to be larger and
more multimodal, ranging in size from many TBs to PBs, with richer metadata. To support the next generation
of neuroscience researchers and to support the scales of computation and storage that will become necessary,
we must archive, preserve, and process this data in a scalable and accessible way that is meaningful to both
neuroscience researchers and software developers. In Aim 1, we will integrate neurophysiology applications
that scientists can easily use on large and diverse datasets to derive new insights and generate interactive
figures, directly connecting the provenance claims to underlying data. In Aim 2, we will expand search
functionality to query into the structure of individual data streams to enable more complex queries that enable
more precise interrogation and advanced analysis of data and help answer more specific neuroscientific
questions. We will improve search to span information within DANDI and to facilitate linking and integration
of DANDI data with related data available in other BRAIN Initiative archives. In Aim 3, we will improve
interoperability of data in DANDI with other neurophysiology software tools, platforms, and applications,
thereby strengthening the ecosystem of neurophysiology research. Community engagement and data reuse will
be further enhanced through yearly workshops aimed at improving the quality of data and metadata and
training users to use DANDI tools and data. Overall, we will address the growing data management and
dissemination needs of the neurophysiology community through a scalable, robust, interoperable, and
standards-based neurophysiology archive that provides an easy to use graphical and interactive interface as
well as computation services close to large datasets that can be accessed simply with a Web browser. We will
provide a platform for seamlessly integrating with and enhancing existing research workflows. We aim to
support scientific inquiry and collaboration, reduce redundancy in computation, and preserve and present
information according to FAIR (Findable, Accessible, Interoperable, Reusable) principles.

Public health relevance
The proposal is to enhance the DANDI archive, an easy to use infrastructure for scientists to share, collaborate, and process data from neurophysiology experiments, which in turn form the basis for understanding cellular level mechanisms of brain function. Performing the proposed research will improve the archive to prepare it for the challenges arising from the significant growth of neuroscientific data. Such open data helps to increase collaboration and benefits researchers, but can also be used as educational materials in high schools and colleges. An open archive will facilitate data publishing and improve access by scientific communities across the world, and can accelerate scientific discoveries about the nervous system.